Paper-based cultures supporting tissue-like structures for biochemical studies of oxygen gradients and screening applications

MIRA Abstract
This MIRA renewal builds upon the success of our efforts to develop a readily accessible culture platform to
generate tissue-like structures and quantify cellular responses in physiologically relevant environments. Oxygen
is a master regulator of cellular function, responsible for systematic reprogramming under hypoxic conditions
and fine-tuning as oxygen supplies decrease. The tissue environment is spatially and temporally dynamic,
responding to changes in oxygen and nutrient supplies as well as localized and systemic gradients of cell-
generated signaling molecules. Despite the complexity of the tissue microenvironment, laboratories have relied
on monolayer cultures due to standardized procedures for setup and analysis. We recognized the need for a
culture platform to study cellular responses in defined tissue-like architectures whose extracellular
microenvironment could be engineered and quantified. The paper-based culture platform represents a readily
adoptable platform, which is modular in design and has a low technical barrier to entry. By stacking cell-laden
sheets of paper, tissues are generated on demand. Our continued efforts include technological advances and
the systematic study of oxygen's role in regulating (1) Estrogen signaling pathways in mammary tissue models.
(2) The post-differentiation of drug-metabolizing enzymes of hepatocytes in a sinusoid model. We showed that
hypoxia alters the regulation of estrogen receptor alpha (ERa) in ER+ breast lines, decreasing transactivation
but maintaining similar amounts of protein in the presence and absence of estrogen. These results are markedly
different from monolayers of the same cells in hypoxia. As we continue to develop the mammary tissue model,
we will include stromal components to determine how they (alone and in concert with hypoxia) alter estrogen
signaling. Our goal is to use a multi-pronged approach to generate a map of the "estrome," visualizing the
transcriptional, translational, and activity changes of ERa and ERb to better predict in vivo outcomes. Our
characterization of HepaRG cells under representative periportal and perivenous oxygen tensions shows its
importance in the post-differentiation expression and activity of drug-metabolizing enzymes and transport
proteins. We will continue to develop a sinusoid model that can characterize the HepaRG cells under a full range
of oxygen tensions that span the sinusoid in vivo, incorporating non-parenchymal cells known to provide
morphogens that promote this process and including flowing medium to simulate the constant exchange
occurring in the sinusoid. The previous funding period's biological inquiries and technological developments
enable these new directions. We will continue to incorporate commonly used analysis tools while developing
ways to characterize the system further while not straying from the original goal of a modular platform that is
both reproducible and quickly adopted. Our biological inquiries will result in more predictable cell-based
platforms, allowing for the: discovery of new biomarkers and treatments, the ability to confidently assess new
drugs for hepatotoxicity and potential drug-drug interactions, and a better understanding of disease progression.

Public health relevance
MIRA Project Narrative This MIRA Renewal will continue efforts in the Lockett Laboratory to develop a modular culture platform for generating readily stackable tissue-like structures. In particular, we will develop technologies to monitor intercellular signaling that alter estrogen signaling in real-time; further develop a method to profile the oxygen-regulated expression of drug-metabolizing enzymes in 3D liver structures; mass spectrometry methods to quantify changes in lipid and metabolite pools in cells under physiologically relevant oxygen tensions.